Meta-Analysis of Behavioral Treatments for Pediatric Feeding Disorders

PROJECT SUMMARY/ABSTRACT
A high percentage of children do not eat or drink at sufficient levels, causing substantial health consequences,
as well as psychological and financial stress for caregivers. Pediatric Feeding Disorders or Avoidant/Restrictive
Food Intake Disorder (ARFID) are especially common in children diagnosed with intellectual and developmental
disabilities and results from complications anywhere in the complex chain of reflexive and learned behaviors.
Children with a severe feeding difficulty (SFD) can learn to associate feeding with pain and discomfort, leading
to intense refusal behavior that leaves caregivers with the inability to feed their children. When children learn
that engaging in refusal behavior successfully avoids meals, refusal behavior can persist even after amelioration
of underlying medical conditions. If refusal persists, a two-phase behavior-based method (1) assesses conditions
maintaining refusal behavior for individual children and (2) bases treatment of refusal behavior on the
assessment through teaching developmentally appropriate feeding skills both to children and caregivers. Though
highly effective, most evidence supporting behavioral treatments for SFD comes from a large number of
published studies using single-case experimental designs. This approach is useful for conducting individualized
treatments, but their format impedes evaluation of the most effective methods and generality of outcomes, and
limits dissemination across scientific communities, caregivers, insurance companies, and healthcare providers.
Limited dissemination among primary health-care providers is particularly problematic because pediatricians are
typically the first contact for child-feeding difficulties, which can result in alternate treatment recommendations
that have little empirical support. Moreover, most insurance companies require prior authorization on a case-by-
case basis for behavioral treatment of SFD, often resulting in delayed or denied coverage for a myriad of reasons
(payor policies not matching evidence-based practice), leading to invasive interventions (g-tube) and deleterious
outcomes for developing children. Therefore, the present research proposes to synthesize and disseminate the
ample evidence for behavioral treatments for SFD with aims to (1) systematically identify and meta-analyze the
range of independent and dependent variables examined from the diversity of methods used, (2) explore the
degree to which demographic variables, number/types of medical diagnoses, and dependence on supplemental
feeding moderate treatment effectiveness, and (3) explore approaches to disseminating treatment effectiveness
by surveying and receiving feedback from key stakeholder groups (caregivers, health-care providers, insurance
companies). Conducting a meta-analysis of these treatments for SFD is a critical step (1) preceding evaluation
through a randomized-controlled trial, (2) toward recognizing it as a medically necessary, highly effective
evidence-based medical approach, (3) that needs to be disseminated across scientific communities, caregivers,
insurance companies, and healthcare providers. Such dissemination would support greater insurance coverage,
increased access to care, and improved health and quality of life of children and their families.

Public health relevance
PROJECT NARRATIVE A high percentage of children experience severe feeding difficulties (i.e., pediatric feeding disorder, avoidant/restrictive food intake disorder) in which they do not eat or drink at sufficient levels, causing serious and substantial health consequences, as well as psychological and financial stress for caregivers. A highly effective behavioral treatment for severe feeding difficulties exists but dissemination across scientific communities, caregivers, insurance companies, and healthcare providers remains limited. The proposed research will quantify effectiveness of behavioral treatments with a meta-analysis to establish the medical necessity of this intervention for severe feeding difficulties, and take initial steps toward creation of dissemination materials, which will improve access to care, resulting in positive impacts on the health and quality of life of children and their families.